Developmental programming of neural circuits integrating drinking and feeding

PROJECT SUMMARY
Developmental programming of neural circuits modulating metabolic state is critical to maintain homeostasis.
Despite an increasing prevalence of metabolic disorders, our understanding of the developmental integration of
neural circuitry linking homeostatic drinking and feeding states remains rudimentary. Agouti-related peptide
(AgRP) neurons are ideally positioned, both anatomically and functionally, to mediate direct communication
within metabolic circuits. Importantly, AgRP neurons respond to developmental cues to project to the
paraventricular nucleus of the hypothalamus (PVH) and the median preoptic nucleus of the hypothalamus
(MePO) during the second week of life. The PVH integrates a variety of neuroendocrine signals, and the MePO
modulates fluid intake with neuronal nitric oxide synthase (nNOS)-expressing neurons activated in response to
thirst to drive drinking. Recent evidence suggests the MePO and PVH are linked by distinct neural connections.
However, the anatomical organization and functional integration between the MePO and PVH has not been
determined, nor has the organization and integration of their neural projections during development been
defined. Evidence in rats suggests circuits controlling drinking function early in life, prior to AgRP projections
reaching hypothalamic targets, suggesting milk intake is controlled by activation of thirst rather than hunger
during the early developmental period. Further, disruptions to developmental cues by over- or undernutrition
appears to decrease AgRP inputs to the PVH. Moreover, prolonged dehydration in adults results in decreased
feeding and body weight until blood osmolality has been restored, implicating close integration of feeding and
drinking. Because the PVH receives inputs from AgRP and nNOS-expressing neurons, it may represent a core
neural node that functions to integrate drinking and feeding states. However, a detailed understanding of the
mechanisms of developmental integration of feeding and drinking is lacking. Because early perturbations specify
the organization of feeding circuitry during critical periods of development, and feeding and drinking have
integrated responses in adults, it is possible that exposure to hypertonic saline during these periods may cause
permanent changes in the architecture of AgRP-regulated circuits in the PVH, and consequently, metabolic
physiology. The overall hypothesis of this application is that activation of neural circuits regulating drinking during
a critical period of development impacts the architecture of feeding circuits with lasting consequences for energy
balance regulation. As a first step toward testing this hypothesis, the following specific aims will be pursued: 1)
Define the developmental time course of neural circuits controlling thirst in neonatal mice; 2) Define how early
exposure to repeated dehydration impacts the development of AgRP inputs to the PVH, and 3) Determine the
subsequent effects on the dehydration-induced anorexia response and neuronal signaling in the PVH in adults.
Completion of these aims will establish a novel framework for understanding how the brain integrates drinking
and feeding with new insight into the developmental events that impact metabolic phenotypes throughout life.

Public health relevance
PROJECT NARRATIVE The events of developmental programming are thought to contribute to an increased prevalence of metabolic disorders, but the physiological events driving the programming of key neural inputs linked to the homeostatic processes of drinking and feeding remain poorly understood. This proposal will be the first step in defining the developmental integration of drinking and feeding states during the neonatal period in the hypothalamus. The results of this proposal will provide new insight into unappreciated developmental events that impact metabolic phenotypes throughout life, which could ultimately lead to new therapeutic targets for metabolic disorders.